SUPPORT SERVICES FOR DEA, OD, NCI

The purpose of this contract is to provide support services to the Office Division of Extramural Activities (DEA), Office of the Director, (OD) National Cancer Institute (NCI).